Intestinal epithelial paracellular permeability and immune tolerance

Project Summary
The long-term goal of our laboratory is to elucidate the molecular basis for intestinal homeostasis and its
dysregulation in intestinal inflammation, and to develop novel approaches for prevention and therapy of
inflammatory bowel diseases (IBD). The apically located inter-cellular tight junctions (TJ) within the intestinal
epithelium act as a selective barrier between luminal and host environment. Although increased intestinal
permeability with loss of intestinal TJ barrier function is associated with intestinal disorders and IBD, the TJ
barrier is complex and context dependent, and the physiological need of epithelial paracellular permeation for
the appropriate gut immune response is being recognized.
The aryl hydrocarbon receptor (AHR), a susceptibility locus for IBD and an environmental sensor, acts as a
class I, basic helix-loop-helix transcriptional regulator. Deficiency of AhR increases severity of experimental
colitis by perturbing intestinal stem cell homeostasis and differentiation and dysregulating the gut immune
responses. On the other hand, activation of the AhR pathway improves colitis outcomes in animal IBD models.
Thus, there is a lot of scientific and clinical interest in the regulation of AhR activity.
In our present studies, and consistent with published reports, we found that the severity of colitis is
increased in intestinal epithelial specific AhR deleted (Ahr∆IEC) mice in several IBD models. Interestingly, we
found that the baseline colonic TJ barrier permeability is reduced in Ahr∆IEC mice. This reduction in colonic
paracellular permeability was accompanied by increased inflammatory tone (increased pro-inflammatory
cytokines and inflammatory phenotype of dendritic cells and macrophages) and impairment of immune
tolerance (reduced IL-10, TGF-β, Foxp3, Programmed death-ligand 1 (PD-L1), and cytotoxic T-lymphocyte-
associated protein 4 (CTLA4)) in Ahr∆IEC mouse colonic mucosa. Based on these findings, we hypothesize that
reduction in the homeostatic paracellular permeability, in the absence of AhR, affects immune
tolerance. We will address this hypothesis with the following specific aims: 1) To determine the mechanisms of
reduced intestinal epithelial permeability in the absence of AhR and 2) To delineate the role of AhR-regulated
paracellular permeability in gut immune tolerance. The proposed studies in Ahr∆IEC mouse model, presents a
unique opportunity to study the role of paracellular permeation in maintaining the gut homeostasis. Once
completed, this study will provide unique knowledge about the role of intestinal barrier in shaping up the
immune homeostasis which can provide a foundation for further investigations to explore pathogenesis-based
therapeutic tools for IBD and other immune-dysregulated diseases.

Public health relevance
Narrative Even though increased intestinal epithelial paracellular permeability is associated with intestinal inflammation and Inflammatory Bowel Disease (IBD), the physiological necessity of paracellular permeability allowing the interaction between lumen and host mucosa is understudied. Using mouse epithelial specific deletion of Aryl Hydrocarbon Receptor which reduces the paracellular permeability but increases severity of experimental colitis, we will test the hypothesis that reduction in the intestinal homeostatic paracellular permeability affects immune tolerance.